Endogenous protein engineering mechanismof oxidative stress in Alzheimer's disease

Alzheimer's is a chronic neurodegenerative disease that affects a large number of aging populations. There is no cure for this disease and understanding the pathologic mechanism is likely the most effective strategy to find the cure. Reactive oxygen species (ROS) cause oxidative stress and play an important role in the pathogenesis of Alzheimer's disease. However, the exact mechanism of ROS action is unknown. ROS oxidize DNA, proteins, lipids and small molecules. Carbonylation is one mode of protein oxidation that occurs in response to iron-catalyzed, hydrogen peroxide (H2O2)-dependent oxidation of amino acid side chains. Although carbonylated proteins are generally thought to be eliminated by the proteasome- dependent degradation, my laboratory discovered the protein de-carbonylation mechanism, in which formed carbonyl groups are enzymatically eliminated without proteins being degraded. Major amino acid residues that are susceptible to carbonylation include proline and arginine, both of which get oxidized to become glutamic semialdehyde that contains a carbonyl group. Further, the oxidation of glutamic semialdehyde produces glutamic acid. Thus, I hypothesize that, through the ROS-mediated formation of glutamic semialdehyde, proline, arginine and glutamic acid residues within the protein structure may be interchangeable. In fact, our recent mass spectrometry results demonstrated that proline 45 (a conserved residue within the catalytic sequence) of the peroxiredoxin 6 protein molecule can be converted into glutamic acid in human cells, establishing a revolutionizing concept that iron-catalyzed oxidation elicits the amino acid conversion within the protein structure in the biological system. The objective of this R03 project is to provide evidence for the occurrence of oxidant-mediated amino acid conversion as a novel mechanism of oxidative stress causing Alzheimer's disease. The objective of this application will be accomplished by pursuing two specific aims: 1) Identify the occurrence of proline 45 to glutamic acid conversion within the peroxiredoxin 6 molecule in brain tissues obtained from patients with Alzheimer's disease; 2) Define effects of the proline 45 to glutamic acid conversion on the peroxiredoxin 6 activity; and 3) Explore the possibility that proline residues within the Tau protein molecule are converted into glutamic acid in the brain of Alzheimer's disease patients. The proposed work is highly innovative because it will address a revolutionizing concept that site-directed mutagenesis/protein engineering-like events occur naturally. Results will be significant because they are expected to provide a new molecular mechanism through which ROS cause neurological damage and help developing strategies to prevent and/or treat Alzheimer's disease.

Public health relevance
Reactive oxygen species (ROS), or oxygen free radicals, are involved in the development of Alzheimer's disease. Carbonylation is one mode of how proteins get oxidized. Although carbonylated proteins are often thought to get degraded in the cell, my laboratory discovered the protein de-carbonylation mechanism, challenging the dogma. Amino acids susceptible to carbonylation include proline and arginine, both of which are oxidized into a molecule called glutamic semialdehyde. Further oxidation of glutamic semialdehyde can produce another amino acid, glutamic acid. Thus, I hypothesize that these three amino acids (proline, arginine and glutamic acid) are interchangeable within a given protein molecule in the biological system. In fact, our recent results demonstrated that proline at position 45 (a functionally important amino acid) of peroxiredoxin 6 protein becomes glutamic acid in human cells. The objective of this project is to provide evidence for the occurrence of ROS-regulated amino acid conversion as a novel biological mechanism in the brain of Alzheimer's disease patients. The proposed work addresses a highly innovative and revolutionizing concept that protein engineering-like events occur naturally. Results will be significant because they are expected to provide a new mechanism through which ROS cause Alzheimer's diseases and thus should help develop new therapeutic strategies to prevent and/or treat this condition.